Project 1: Targeting the PD-1 pathway in HCC

Project 1 – SUMMARY/ABSTRACT
The multi-kinase inhibitors, sorafenib (first-line use) and regorafenib (second-line use), have been approved for
the treatment of advanced HCC; however, the overall survival improves by less than 3 months and the overall
response rates are low (<10%). Resection and liver transplantation are curative treatments for HCC; however,
less than 20% of HCC patients are eligible for resection and early recurrence is frequent (50% in 2 years).
Because the predominant molecular alterations in HCC are not druggable, targeting immune checkpoints such
as programmed cell death 1 (PD-1) and cytotoxic T-lymphocyte-associated protein 4 (CTLA-4) may be a
promising alternative strategy. The anti-PD1 drug, nivolumab, was recently approved for HCC therapy. With a
20% response rate, anti-PD1 therapy is encouraging, opening opportunities for more effective therapeutic
approaches. In resected HCC samples, we found tumor-infiltrating T cells expressing PD-1 and CTLA-4,
surrounded by a dense macrophage infiltrate rich in the checkpoint ligands PD-L1 and PD-L2. While increased
immune response by targeting PD-1 and CTLA-4 pathways has been reported in unresectable HCC,
immunotherapy strategies have not yet been evaluated in neoadjuvant (pre-surgery) and adjuvant (post-surgery)
settings. In a pilot randomized perioperative trial with nivolumab ± ipilimumab (anti-CTLA-4) for resectable HCC,
we observed complete pathologic responses in 2 cases that correlated with an increase in CD8+ T cell infiltration
and CD8/Treg ratio. Based on the 6 patients accrued to date, none had drug related events that led to delaying
or canceling surgery and we didn’t encounter grade 3 or 4 adverse events. The tyrosine kinase c-MET is
overexpressed in HCC, and multiple c-MET inhibitors have been developed and evaluated in clinical trials in
HCC. However, the reported outcomes were disappointing. We showed that c-MET inhibitors upregulate PD-L1
expression in HCC cells, which may allow HCC cells to escape from T cell killing. We further showed that the
combination of c-MET inhibitors and anti-PD-1 synergistically suppresses HCC development in mice. Our long-
term translational goal is to modulate immune cells in HCC microenvironment to improve outcome in patients
with advanced HCC or resectable HCC. We hypothesize that neoadjuvant immune checkpoint therapy in HCC
can trigger an immune response which may lead to delay in recurrence or increased resectability, and that
immune infiltration or fibrosis stage can affect treatment response. We also hypothesize that the efficacy of
HCC immunotherapy can be improved by simultaneously targeting immune checkpoint signaling and checkpoint
molecule expression. In Aim 1, we propose a neoadjuvant/adjuvant clinical trial targeting PD-1 ± CTLA4 in
surgical HCC patients to delay recurrence and in locally advanced unresectable HCC patients to increase
resectability. In Aim 2, we will evaluate novel combination therapies including anti-PD-1 and agents upregulating
PD-L1 expression, such as c-MET inhibitors, in HCC. The impact of this project would be increased access to
surgery for a larger number of HCC patients and improve overall survival in patients with advanced HCC.

Public health relevance
Project 1 - Narrative Our recent studies on resected hepatocellular carcinoma (HCC) found tumor-infiltrating T cells expressing PD- 1 and CTLA-4 surrounded by a dense macrophage infiltrate rich in checkpoint ligands, justifying a trial to test innovative immunotherapy in HCC. The goal of Project 1 is to evaluate the ability of immunotherapy drugs to down size HCC tumors to make them amenable for resection, and also to study their ability to lower the high rate of HCC tumor recurrence after surgery. We will also evaluate novel drug combination strategies by simultaneously targeting immune checkpoint signaling and checkpoint molecule expression.